Inflammation and Aortic Aneurysm Pathophysiology

DESCRIPTION (provided by applicant): The lack of understanding of molecular mechanisms underlying abdominal aortic aneurysm (AAA) currently limits the prevention and treatment of this human disease. Previous studies by the applicants and others established profound inflammation associated with a predominantly lymphocytic infiltrate, the loss of extracellular matrix, and the paucity of smooth muscle cells as prominent morphologic characteristics of human AAA. Based on these and further preliminary studies presented here, the applicants propose a novel hypothesis regarding the inflammatory triggers and downstream effector mechanisms of extracellular matrix destruction yielding AAA. Specifically, we propose that the formation of human AAA is promoted by the expression of inflammatory triggers of the TH2 lymphocyte subset and/or the absence of TH1-associated cytokines, as well as the imbalance of downstream elastolytic, collagenolytic, or apoptotic effectors with their endogenous inhibitors. In Specific Aim 1 we will test this hypothesis in vitro and in situ, phenotyping the leukocyte subpopulation(s) and characterizing expression of the respective upstream triggers (TH1/TH2 cytokines) as well as downstream elastolytic and collagenolytic (cathepsins, MMPs) as well as apoptotic (caspases, Fas/FasL) effectors, employing carefully characterized human AAA specimens. Studies determining the modulation of these downstream effectors by TH2 cytokines (particularly in the absence of TH1 typical cytokines) will elevate this aim to the functional level. The studies testing the novel propagated molecular mechanisms underlying AAA pathophysiology will be compared to those obtained in the predominantly TH1-driven aortic occlusive disease. In Specific Aim 2 we will test this hypothesis in vivo in genetically altered mice. In a novel aortic transplant model, established by the applicants, we will test whether the systemic or local deficiency of distinct TH1/TH2 cytokines (IFNgamma, IL-4, or IL-10) as upstream triggers, or imbalance of downstream etastolytic/collagenolytic effectors with their endogenous inhibitors will yield aortic ectasia, a model of aneurysmal disease. In addition, these experiments will employ hypercholesterolemic compound mutant mice, combining a predominant TH1 or TH2 skewed immuneresponse or the systemic imbalance of elastolytic/collagenolytic activities with the predisposition to atherosclerotic disease (apoE deficient mice), to test whether modulations in defined inflammatory or proteolytic paradigms, respectively, affect AAA formation differently when exposed to an atherogenic background. Combined, the two Specific Aims will determine whether differential immune mediator-associated mechanisms triggering proteolytic and apoptotic effectors regulate the development of the two diametrically opposed expressions of aortic diseases-AAA and AOD.